Training

Project Summary Training activities will be incorporated into the Yeast Resource Center at multiple levels. Many of these training components and resources are already in place within our resource. We intend to use this pre-existing and established infrastructure of training activities such as on-site short courses, workshops and short courses at scientific meetings, providing opportunities for visiting scientists to learn our methods with center personnel, on-line tutorials, use of the Center's web site for resource sharing and training in the use of the technology and tools developed. We will build on this infrastructure and a track record of offering comprehensive training opportunities to the scientific community.